Abnormalities in androgens and ovarian markers in reproductive-age racially and ethnically diverse women in a prospective longitudinal cohort

Polycystic ovary syndrome (PCOS) is the most common endocrinopathy among reproductive-age women and
characterized by hyperandrogenemia, irregular menses, and enlarged polycystic ovaries. The genetic
architecture of PCOS also includes obesity and insulin resistance, and thus women with PCOS often have
elevated body mass index (BMI) and glucose intolerance. In October 2021, the NIH convened a PCOS
workshop; co-I Siscovick reported on knowledge gaps regarding PCOS and cardiovascular disease (CVD).
First, best practices for identification of abnormal androgens, menses, and ovarian markers are unclear,
particularly as women age. Cutpoints for abnormal values are arbitrary and based upon expert opinion; the
predictive value of serum ovarian markers compared to radiographic markers is not accepted; and optimal
tests for blood androgens is uncertain. Second, it is not understood how PCOS characteristics and
subphenotypes differ by race and ethnicity; socioeconomic status (SES); and potentially modifiable factors
such as BMI and oral contraceptive use (OCP). Third, it is unclear to what extent PCOS characteristics predict
risk for cardiometabolic disease beyond standard risk factors. Similarly, it is unknown if PCOS subphenotypes
confer different risks of cardiometabolic disease. These issues are best addressed using population-based
prospective cohorts spanning reproductive age to older age, as such studies minimize biases in referral and
ascertainment of outcomes. However, such studies are few. The Coronary Artery Risk Development in Young
Adults Study (CARDIA) and the Dallas Heart Study (DHS) are two population-based, prospective, longitudinal
cohorts which first sampled Black and white participants during their reproductive years (age 18-30 years in
CARDIA, age 35-49 years in DHS) and have followed their cohorts to late middle age. The studies used
identical questionnaires for ascertainment of menstrual history and exogenous estrogen use. Both studies
have deeply phenotyped women with repeated measures of traditional and novel CVD risk factors,
intermediate atherosclerotic markers including coronary artery calcification (CAC), adjudication of CVD events,
and radiographic assessment of ovaries. Our team, consisting of PIs of these studies, and experts well-versed
in the controversies of PCOS, will build upon this rich infrastructure. We will use existing data and samples
from reproductive-age women in both studies (n=1163 in CARDIA, approximately half of whom were Black;
n=827 in DHS, approximately two-thirds of whom were Black, 25% non-Hispanic white, and 10% Latina). We
will measure androgenic metabolites including 11 oxy-androgens using state-of-the-art mass spectrometry and
anti-Müllerian hormone (AMH) and sex hormone binding globulin (SHBG). We will apply machine learning
strategies to generate cutpoints and PCOS groupings, compare these to conventional definitions and
phenotypes, and examine associations by racial and ethnic group, SES, and OCP use. Finally, we will examine
prospective associations with cardiometabolic risk, particularly events. No additional data collection is needed.

Public health relevance
Project Narrative It is not known whether screening for abnormalities in androgens or ovarian markers, hallmarks of polycystic ovary syndrome, is helpful for reducing cardiovascular disease risk. It is unknown if doing so could identify women for interventions to reduce risk, particularly because such abnormalities accompany other factors like obesity that are already measured and also more easily measured. We can address this issue by performing state of the art assays in two racially and ethnically diverse studies that have ongoing data collection with the aim of determining which factors might reduce risk in women.